PHARMACOLOGY OF A THROMBOXANE SYNTHASE INHIBITOR AND RECEPTOR ANTAGONIST IN MAN

The specific objectives of this study are to examine the pharmacodynamic and pharmacokinetic effects of CGS 22652 (50, 150, 450, 900 and 1350 mg) when administered as a single oral dose to healthy male volunteers.